Molecular Biology and Cytometry Research Shared Resource

MOLECULAR BIOLOGY AND CYTOMETRY RESEARCH SHARED RESOURCE: ABSTRACT
The Molecular Biology and Cytometry Research Shared Resource (MBCR SR) is an institutionally managed
central core facility that assists investigators in all aspects of research, including initial project consultation,
assistance with experimental design, training in protocols and instrumentation usage, sample preparation, data
collection and assistance with analysis and interpretation of results. Under the direction of Ken Jones, PhD,
the MBCR SR provides six important core services to Stephenson Cancer Center (SCC) members and other
investigators: 1) the DNA Sequencing and Genomics Core provides high-fidelity, next-generation nucleic acid
sequencing data; 2) the Proteomics Core provides support for biomolecule identification, including complex
proteomics analysis, post-translational modification identification, high-resolution molecular weight
determination, large biomolecular mass measurements, LC-UV-MS analysis (qualitative or quantitative),
protein identification by proteolytic digest (in-gel or in solution), nano LC/MS/MS and database search, and
peptide sequencing; 3) the Flow Cytometry and Imaging Core provides flow cytometry and microscopy support
for subcellular studies on protein expression, cell cycle and cell signaling; 4) the Cancer Functional Genomics
Core provides high-throughput live cell functional characterization of cancer cells, including reverse proteomics
array establishment, absolute gene quantification and copy number determination, nucleic acid and protein
electrophoresis and imaging, multimodal screening for high-throughput assay on plates, high-throughput, high-
content screening of subcellular localized proteins in cells, metabolic analysis of live cells and quantification of
clonogenic assay colonies of cancer cells; 5) the Bioinformatics Core provides advanced computational
analyses of multi-omic data (Genomic, Proteomic, Metabolomic), and 6) the Mass Spectrometry Core is a
nascent core initiated in 2021 as an institutional core specializing in metabolite and small molecule analysis
using state-of-the-art mass spectroscopy. This SR has been successful in obtaining funds to purchase
metabolomic mass specs for de novo discovery and targeted analysis. The MBCR SR is located in the Stanton
L. Young Biomedical Research Center (BRC) on the University of Oklahoma Health Sciences Center (OUHSC)
campus. This central location provides convenient access to the MBCR SR for the SCC’s laboratory-based
members (37 members in BRC, 15 members in the adjacent Biomedical Sciences Building). During the
reporting period, 78 full and associate SCC members utilized this facility, with 69 (88%) of these having peer-
reviewed grant support. Since this is an institutionally managed core that supports the entire OUHSC campus,
it is important to note that full and associate SCC members (n=78) accounted for over a third (35%) of the total
users of this centralized facility (n=222). SCC affiliate members (non-CCSG members) accounted for another
27 (12%) of total usage. Combined, these cancer focused members account for by far the largest number and
percentage usage by any department or center at OUHSC.